Investigating Obesity and Chronic Disease-Related Risk Factors of Alaska Natives

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To enable and provide stronger reliable evidence on which to base decisions on health interventions and the focus of future intervention research.